California Clinical and Translational Pain Research Consortium

Abstract
The University of California Clinical and Transla�onal Pain Research Consor�um (CCTPRC) was
awarded the NIH U24 (NS115714) grant in 2019. The budget was reduced when the U24 was
awarded. This required us to reduce eﬀort for the Inves�gators, PM and study coordinator.
Although we were able to streamline the eﬃciency and costs by combining redundancy
between other NIH HEAL grants across the CCTPRC, the higher-than-expected screen/screen
failure ra�o for the EN20-01 and EN21-01 studies strained the budget with funds running out
March 2024. We are asking for addi�onal funds to get us through the 5-year budget period.
We will use the funds toward other recruitment methods for the two studies u�lizing
bioinforma�cs to search the EHR for qualiﬁed subjects. Two methods will be used, batch
emailing and cold calls. We will monitor success of screen to randomiza�on ra�o and revert to
the method yielding the highest randomiza�ons. This will also allow us to reﬁned recruitment
eﬀorts for future EPPIC-Net studies.

Public health relevance
Narra�ve This administra�ve supplement aims to provide con�nued support to the California Clinical and Transla�onal Pain Research Consor�um (CCTPRC) to con�nue recruitment eﬀorts and randomiza�on into the EN20-01 and EN21-01 studies.